Bioinformatics Framework for Wastewater-based Surveillance of Infectious Diseases

Project Summary
COVID-19 is expected to become one of the largest mass casualty events in the history of the United
States (U.S.). Assessment of the true burden of disease in the population is needed for the prevention and
mitigation of this and future viral disease outbreaks. Currently, testing of new cases (via swabs / saliva) and
those previously exposed (via serum) has limited reach in the population. However, an alternative approach
relying on the analysis of community wastewater can screen up to 70% of the U.S. population on a weekly
basis at <0.01% of the cost of clinical screening of individuals. As a population-wide infectious disease
surveillance tool, wastewater-based epidemiology (WBE) can be used to complement current surveillance
methods to better understand disease burden and how these burdens differ across communities.
The goal of our proposed RADx-rad supplement is to implement and evaluate a near real-time WBE
framework for SARS-CoV-2 by (i) assessing in near real-time community spread of the new coronavirus, (ii)
significantly increasing the fraction of the U.S. population screened, the frequency at which this testing is being
completed (weekly) and the geospatial resolution of screening (from city-wide to neighborhood-specific), (iii)
comparing novel coronavirus levels in wastewater with the burdens of infection, disease and mortality reported
by local health systems, (iv) harvesting high throughput sequence (HTS) data on SARS-CoV-2 variants across
the U.S., (v) optimizing pipelines for HTS analysis, and (vi) immediately sharing any new knowledge gained
with the RADx-rad Data Coordinating Center (DCC), research community, and the general public via an
expansion of our online dashboard that was pioneered by the proposing team in collaboration with the City of
Tempe, AZ.
We will leverage previously developed, peer-reviewed strategies for population-wide virus monitoring via
reverse transcription real-time polymerase chain reaction (RT-qPCR), HTS, sequence analysis, and data
communication originally developed for our parent award to quickly provide a data stream and scientific
resource for managing the COVID-19 epidemic in the U.S.
In Aim 1, develop a wastewater-based epidemiology (WBE) bioinformatics framework for SARS-CoV-2 at
the national, city and intra-sewershed or neighborhood-level to produce RT-qPCR and SARS-CoV-2 RNA-seq
data for studying the distribution of viral levels and genetic polymorphisms in the community. In Aim 2, we will
evaluate a WBE bioinformatics framework for translating SARS-CoV-2 data from RT-qPCR and high-
throughput sequencing into information for monitoring population health.
Successful completion of this biomedical informatics project will provide the U.S. with an early warning
system for SARS-CoV-2 detection and a tracking aid for public health epidemiologists seeking to reduce
morbidity and mortality from infectious diseases like COVID-19 in the U.S.

Public health relevance
Project Narrative This RADx-rad project will utilize wastewater-based epidemiology (WBE) and biomedical informatics to monitor SARS-CoV-2 across multiple U.S. cities. It will examine WBE at different scales (national, city and intra-sewershed or neighborhood-level), the geographic distribution and frequency of single nucleotide polymorphisms (SNPs), and the potential of WBE as an early indicator for changes in community level infection trends. Successful completion of the work will lead to a better understanding of how WBE can support population-level monitoring of SARS-CoV-2 and similar infectious disease threats.